Core Vision Grant

Project Abstract
Twenty-four investigators from the University’s Faculty of Arts and Science and School of Medicine request
support for their vision research through continuation of a Core Grant. They are bound together by their
research interests in the biological and behavioral bases of eye disease, vision, and visually guided behavior.
The proposed Core will comprise four modules, each of which will benefit research in the research areas
represented by program faculty: a Functional Imaging Module, a Design and Fabrication Module, a
Neuroanatomy Module, and a Translational Reseach Module.

Public health relevance
Project Narrative The work of the members of the Vision Core at New York University seeks to understand the functional basis for vision and visually guided behavior, the way in which these are disrupted by visual disorders, and the way these disorders can be detected and treated. To enhance this work, we request continuation of a Core Grant, comprising four modules, each of which will benefit research in the areas represented by members of the core and enhance their contribution to understanding vision in health and disease.